Role of TGFBR3 in T-cell development and immune response

DESCRIPTION (provided by applicant): The goal of this exploratory proposal is to study the role of TGFβR3, also known as betaglycan, in T-cell development and immune responses. Although TGFβR3 is broadly expressed in cells of both the innate and adaptive immune system, very little is known about its function in immunity. Loss of expression of TGFβR3 in several cancers is associated with poor prognosis. We have recently reported that TGFβR3 expression in thymocytes is developmentally regulated, and interruption of its signaling leads to inhibition o T-cell maturation. TGFβR3-null mice exhibit embryonic lethality which has hampered studies to determine its function in the immune system. We have developed a novel conditional TGFβR3fl/fl mouse that offers the opportunity to selectively target the inactivation of TGFβR3 in tissues of choice. We show that induced inactivation of TGFβR3 in the adult mouse leads to profound changes in T cell development. In mature T cells, inactivation of TGFβR3 enhanced Th1 differentiation but diminished Th17 differentiation. These results reveal an indispensable function for TGFβR3 in T cell development and differentiation. TGFβR3 is a coreceptor and enhances the binding of TGF-β family of molecules to TGFβR1/TGFβR2 heterodimer leading initiation of intracellular signals. TGFβR3 also binds to inhibins with high affinity to antognize activin-dependent signaling. In addition to TGFβR1/TGFβR2 associated activity, TGFβR3 can also independently modulate intracellular signals associated with activation and migration. For this proposal, the specific aims are: (1) to determine the role of TGFβR3 in T cell development and selection; (2) to determine the role of TGFβR3 in modulating the differentiation of naïve T cells to effector cells and autoimmunity. Our proposed studies will move the field forward in our understanding of the biological properties of TGF-β family of proteins with opportunities to develop new strategies for promoting immunity and/or targeting autoimmunity.

Public health relevance
PUBLIC HEALTH RELEVANCE: The goal of this proposal is to study the function of a poorly understood cell surface expressing protein called transforming growth factor receptor 3 (TGFβR3) in immunity and autoimmunity. The lack of this protein leads to embryonic lethality; therefore we developed a novel mouse model in which TGFβR3 can be conditionally deleted in selected tissues to dissect its role in the immune response. The approach in this proposal will set a path for the development of new strategies for modulating the immune response and/or treat autoimmunity.